Mechanisms of plasticity and repair after SCI

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To expand the imaging core capabilities through the addition of a Live Cell Imaging System. This will greatly accelerate several Centers of Biomedical Research Excellence- sponsored projects.